ANTIGEN PROCESSING IN LOWER EUKARYOTIC CELLS

CD8+ T cells (TCD8+) recognize class I molecules of the major histocompatibility complex (MHC) bearing peptides of 8 to 10 residues derived from cytosolic proteins. These cells are a bulwark of host defenses to infectious agents and tumors and if we are to improve existing vaccines and develop new vaccines and treatments for infectious and neoplastic diseases, it is critical to understand antigen processing, the mechanism by which antigenic peptides are generated by cells and delivered to class I molecules. Although there has been great progress in understanding antigen processing in the past 5 years, there remains much to be learned. The strategy of this project is to delineate what we don't know. We are expressing the known constituents of the antigen processing machinery in mosquito cells, and determining whether this is sufficient to reconstitute antigen processing to a level seen in mammalian cells. Insects do not have a MHC, and do not therefore, have any of the specialized machinery associated with antigen processing. If these cells can process antigens under these conditions, this would indicate that we have identified the major components of antigen processing, if they can't, it would mean that further discoveries are required. In the past year we made considerable progress in setting up a workable system, and are poised to gain solid information regarding this question.